Impact of a Glucagon-Like Peptide-1 Receptor Agonist administration on SIV/HIV pathogenesis and ART

Antiretroviral therapy (ART) administration to people living with HIV (PWH) associates significant weight gain
and dramatic (>30%) increase in visceral and abdominal adipose tissue (AdT). Obesity and AdT hypertrophy are
accompanied with inflammation, type 2 diabetes and cardiovascular disease. Since metabolic disease is now
diagnosed in >70% of PWH on ART, this is a major clinical burden and threat to lifespan. Visceral AdT (VAT)
represents a major HIV reservoir, the persistence of which thwarts virus eradication. In our pigtailed macaque
(PTM) model of HIV infection, ART administration mirrors with high fidelity the major elements of metabolic
disease in PWH: accumulation of inflamed VAT, weight gain, high levels of oxidized HDLs, increased plasma
levels of free fatty acids, hypercholesterolemia and hypertriglyceridemia. CA-vDNA levels in cells isolated from
fat confirmed AdT as a key SIV reservoir. We thus hypothesize that by increasing VAT and altering lipid
metabolic profiles, HIV/SIV and ART cause AdT infiltrating T cells and macrophages to become
dysfunctional, through adipose lipid-driven changes to immune cell metabolism, activation, and
proliferation. These immune cell dysfunctions promote inflammation and virus persistence in AdT. We
will use our PTM model, a first line ART used in PWH, and an FDA approved weight loss drug to dissect the host
immunological and metabolic processes involved in the persistence of the AdT SIV reservoir, residual INFL and
associated comorbidities. We will: 1) Assess specific changes of T-cell and macrophage metabolism by SIV and
ART in relation to immune cell activation, proliferation, differentiation and function in AdT. 2) Measure the antiviral
cellular immune responses in AdT. 3) Assess the cellular sources of inflammation in AdT. 4) Measure the size
of AdT virus reservoir. 5) Establish the lipid profile induced by SIV/ART in blood and AdT. 6) Test the ability of
plasma and AdT-derived lipids to directly evoke changes in T cells and macrophage subsets. We will thus
establish how VAT size and lipid composition lead to changes in AdT T-cell homeostasis and CTL frequency
and function versus the persistence of viral reservoir. We will also assess how dysfunctional T cells and
macrophages induce AdT inflammation. We will then use a GLP-1 agonist to alter the size and distribution of
AdT and modify the metabolism and function of the immune cells that infiltrate AdT. The GLP-1 agonist will be
administered either after months of ART administration or concomitantly to ART initiation to either alleviate or
prevent the adverse metabolic effects induced by ART in the AdT. The impact of our intervention will be assessed
in AdT and systemically. These mechanistic studies can only be performed in models of SIV and ART, and target
mechanisms pharmacologically relevant for obesity and inflammation in the general population. Their successful
completion will provide proof-of-concept data showing that the clinical management of the PWH would benefit
from targeting AdT and other metabolic disturbances induced by infection and ART.

Public health relevance
There is an epidemic of obesity in people living with HIV (PWH) due to antiretroviral therapy (ART) and use of unhealthy diets. By predisposing PWH to metabolic disturbances and comorbidities, both leading to higher mortality compared to age-matched uninfected subjects, weight gain is detrimental: the immune cells infiltrating adipose tissue are dysfunctional and allow virus persistence, one of the main obstacles to an HIV cure. Reducing the inflammation in AdT may be reduce the incidence of comorbidities in PWH. We will investigate the metabolic and immunologic host factors responsible for HIV/SIV persistence in the AdT and we will perform a proof-of- concept intervention to prevent or alleviate the metabolic adverse effects induced by HIV/SIV and ART and to assess its potential impact on the natural history of treated SIV infection.